Genetics of central serous chorioretinopathy and choroidal thickening

PROJECT SUMMARY
Overview: This resubmission describes a 4-year training program in statistical genetics through the study of
genetics of central serous chorioretinopathy (CSC) and choroidal vasculature.
Background: CSC is a disease of the choroid and retina seen commonly by retina specialists, and it causes
progressive vision loss. Patients tend to have a thick and dilated choroid. Evidence suggests that both CSC
and choroidal thickness are heritable, but only a handful of loci have been reported. Discovery of new genetic
associations for CSC can reveal underappreciated pathophysiologic mechanisms. CSC shares some genetic
overlap with age-related macular degeneration (AMD), and a better understanding of CSC and choroidal
vasculature genetics is needed. This K23 proposal seeks to identify common genetic variation associated to
CSC and choroidal thickness and to investigate how this variation overlaps with known genetic associations to
AMD.
Training: The proposal is designed to provide foundational training in statistical genetics and automated
optical coherence tomography (OCT) image analysis for the PI, Dr. Elizabeth Rossin, who will learn these skills
from mentors, collaborators, seminars and training sessions. This training will cover techniques of data
assembly and quality control of biobank data, the approach to genome-wide association study and meta-
analysis, and skills of patient recruitment and prospective genotyping for the clinician-scientist. It will foster
experience in the use of existing OCT and genetic data to develop skills in the application of machine learning
to choroidal measurements on OCT and additional statistical genetics skills for quantitative trait analyses.
Finally, the PI will learn genetic correlation analysis, an area of genetics that is becoming increasingly
important to understand shared biological mechanisms in disease, here applied to CSC and AMD.
Research: Aim 1 proposes to perform a CSC genome-wide association study (GWAS) meta-analysis across
biobanks and available data and to replicate findings in a deeply phenotyped cohort of prospectively recruited
patients. Aim 2 proposes to measure a hallmark of CSC – choroidal thickness – on OCT and to perform
quantitative trait GWAS meta-analyses. Finally, Aim 3 investigates the overlap of CSC and AMD genetics
using modern statistical approaches including LD-score regression and colocalization. This proposed research
seeks to identify novel loci for CSC and choroidal thickness and to link this to AMD, which can point to critical
pathways in macular disease.
Summary: Through this K23 mentored training, the PI intends to develop skills that are applicable broadly to a
career in patient-oriented retinal genetics research.

Public health relevance
PROJECT NARRATIVE The etiology of central serous chorioretinopathy (CSC) and associated choroidal anatomy is poorly understood and could be better understood through discovery of genetic risk factors. Despite its being the 4th most common maculopathy, its substantial morbidity in a younger population and its phenotypic and genetic overlap with age-related macular degeneration (AMD), CSC lacks pathophysiologic understanding and treatment options. Discovery of the genetic underpinnings of CSC and choroidal thickening (and how they relate to those of AMD) could lead to a better understanding of the pathophysiology of CSC, and it could point to molecular pathways on which to intervene.